Developing mRNAdesigner tool package for optimization of mRNA sequence

Abstract
The goal of this project is to develop a platform called mRNAdesigner, an integrated deep learning model to
optimize 5'UTR, codon usage, and 3'UTR at same time, which enables users to design the optimal mRNA
sequence to enhance protein expression level, thus to improve the mRNA translation efficiency
mRNA medicines have several beneficial features: safety, efficacy, production, and speed. It is a significant
challenge for all of the researchers to maximize the translation efficiency of mRNA vaccine. Multiple factors are
involved to regulate the stability and efficiency of mRNA, including 5' untranslated region (UTR), 3' UTR, codon
et al, and several in silico approaches have been developed to optimize these factors respectively However, as
these factors always function together during the translation of mRNA, and individual optimization is insufficient.
Thus, a novel integrated deep learning model for these factors is needed to comprehensively enhance the
stability and efficiency of mRNA medicine. We propose to develop a platform mRNAdesigner that will address
the challenges in design of mRNA sequence to enhance mRNA stability and translation efficiency, and thus
provide important information for the development and optimization of mRNA vaccines. mRNAdesigner includes
three components: mRNAbase, mRNAoptimizer, and mRNAviewer. mRNAbase is a database to collect high
translational efficiency gene data, the optimized mRNA sequence of ORF, 5' UTR and 3'UTR for any target
proteins, the energy, secondary structure, and functional annotation of those optimized mRNA sequence of ORF;
mRNAoptimizer, in silico deep learning optimization of mRNA sequence, provides a fast methodology to
investigate all possible integration of the ORF, 5' UTR and 3'UTR and identify the optimal mRNA sequence; and
mRNAviewer to visualize the optimized mRNA sequences, the secondary structures and the related functions.
Finally, the integrated models by designing the 5'UTR, codon, and 3'UTR sequence for representative will be
experimentally validate in vitro and in vivo. Software prototypes mRNAdesigner including mRNAbase,
mRNAoptimizer, and mRNAviewer will be made publicly available to the research community via a project
website at https:/ccsm.uth.edu/NSF-mRNAdesigner.

Public health relevance
Narrative The goal is to develop an integrated deep learning model to optimize 5'UTR, codon usage, and 3'UTR at same time that enables users to design the optimal mRNA sequence to enhance protein expression level, thus to improve the efficacy of mRNA medicines. mRNA based therapies hold great promise for the treatment of various types of diseases, but this therapeutic approach suffers from multiple challenges including the short half- life of exogenously administered mRNA and subsequent protein production. Our proposed studies will address the challenges in design of mRNA sequence to enhance mRNA stability and translation efficiency, and thus provide important information for the development and optimization of mRNA vaccines.